POSTURAL EFFECTS ON PLASMA LIPOPROTEINS AND APOLIPOPROTEINS

We examined the time course of plasma lipoprotein and apolipoprotein concentration changes in six volunteers upon changing from the standing to sitting or supine positions and back. Recumbence produced an 8-10% decrease in TC,HDL-C, apolipoproteins A-I and B, and Lp(a), and a 17% decrease in triglycerides. The changes were half as great upon sitting. The changes were reversed upon standing, and all changes were complete within 20-40 minutes.